Influence of Mixed Retrovirus Infections on Leukemia and Neurological disease

The induction of many diseases in mice by murine leukemia viruses (MuLVs), involves the participation of variant retroviruses termed polytropic MuLVs. These include the induction of proliferative, immunological and neurological disorders. Polytropic MuLVs are formed by recombination of exogenous ecotropic MuLVs with endogenous envelope sequences present in the genomes of inbred mouse strains resulting in viruses that utilize a distinct cell-surface receptor for infection. The infectious host range of ecotropic MuLVs is limited to mice; however the recombinant polytropic viruses generated after inoculation of mice with ecotropic MuLVs are capable of infecting a number of other species as well as mice. Thus, the generation of polytropic viruses results in a mixed retrovirus infection of viruses with different infectious properties. Our earlier studies strongly suggest that the interactions of ecotropic and polytropic MuLVs in the host play a role in facilitating oncogenesis. More recently we have investigated the interactions of retroviruses in mixed infections in vivo by co-inoculation of mice with mixtures of polytropic MuLV isolates and ecotropic MuLVs. Mice infected with defined mixtures of retroviruses exhibit dramatically altered pathology compared to infection with the individual viruses of the mixture. These included a highly significant delay in the induction of proliferative disease with one polytropic MuLV and a profound synergistic effect resulting in the abrupt development of a neurological disease with another polytropic isolate. In both instances the polytropic virus load in the co-inoculated mice was markedly enhanced while the level of the ecotropic MuLV was unchanged. Furthermore, the polytropic MuLV was nearly completely pseudotyped within ecotropic virions in co-inoculated mice. There are a number of possible mechanisms which could facilitate the profound in vivo amplification of the polytropic MuLVs including enhanced spread of the virus due to pseudotyping within ecotropic virions or possibly transactivation of the polytropic virus in co-infected cells. To examine these questions in a less complex system we have extended these studies to examine mixed retrovirus infections of an in vitro cell line. We have found that co-infection of polytropic MuLVs with ecotropic or amphotropic viruses results in amplification and pseudotyping characteristics remarkably similar to what we have observed in vivo. The polytropic infectivity released from co-infected cells is markedly increased while the ecotropic infectivity remains unaltered. Further, the increase in infectivity is accompanied by extensive pseudotyping of the polytropic genome within ecotropic virions. This observation extended to cell lines from different tissues and different mice indicating that it was a feature of the components of the mixed infection rather than a property of the cells. The elevation of polytropic MuLV infectivity released from co-infected cells could have resulted from an increase in the level of polytropic genomes released. Alternatively, the observed increase could reflect a much higher specific infectivity of ecotropic or amphotropic virions compared to polytropic virions. We have found in polytropic MuLV mixtures with either ecotropic or amphotropic MuLVs, that at least some of the increase in polytropic virus titer can be attributed to an increase in the efficiency of packaging and release of the polytropic genome from co-infected cells. Analyses of clonal cell lines releasing different levels of polytropic viruses indicated that each of these lines could be induced to release similar high levels of polytropic virus upon co-infection of these cells with an ecotropic virus. These results further suggest that co-infection with an ecotropic virus facilitates the packaging and release of the polytropic genome, possibly reflecting an inherent defectiveness of thhhe polytropic envelope. In this regard, unlike ecotropic and amphotropic viruses, recombinant polytropic viruses are chimeric viruses in which the envelope of the virus has not co-evolved with the other structural genes. Thus the envelope protein of polytropic viruses may not function as efficiently in packaging and release of progeny viruses. In 2015 we have continued studies with clonal cell lines. Many of the cell lines released moderate to high levels of the polytropic MuLV, however some lines released only low levels of infectious virus. Virus harvested from the clones and used to infect new cells did not exhibit substantial differences in their ability to replicate, indicating that the deficiency in virus release from the clonal cell lines reflected different properties of the cells rather than the viruses. Upon superinfection by the ecotropic MuLV, we observed enormous increases (40-50,000-fold) in the release of polytropic infectivity from the cells. This remarkable increase of polytropic infectivity was not the result of an increase in polytropic RNA transcription or an increase in the release of virion polytropic RNA from the cultures. Rather, our results suggest that the clones release an overwhelming proportion of non-infectious virions that may be a result of a deficiency in polytropic envelope protein incorporation. If this is the case, the deficiency appears to be polytropic env-specific in that it was compensated by incorporation of the ecotropic MuLV envelope protein upon superinfection, rendering the released virions infectious. Other possible explanations for the increase in infectivity are currently under investigation.